INTERDISCIPLINARY TRAINING IN GERONTOLOGY

This proposal requests a 5 year continuation of the predoctoral interdisciplinary research training program in Gerontology at Penn State. Twelve predoctoral positions are requested for each year of the program. This training program builds on a successful foundation of training and research at Penn State. A cornerstone of the program is a distinguished and large research faculty with active programs of funded research who serve as Faculty Preceptors for trainees. The program combines a balance between breadth and depth which is optimal for predoctoral training. Breadth is provided through 3 core courses on biological, psychological and sociological issues in aging, an on-going research colloquium and other experiences. Depth in research training is achieved by completion of discipline-based course work, research methodology and statistics, and, especially, through work with Faculty Preceptors. Preceptors provide hands-on research training, including supervision of trainees' independent doctoral research. A rich training environment is provided by opportunities to work on an extensive group of funded investigations, resources available through various laboratories and Centers which faculty are affiliated with, and other University resources. Three areas of research are emphasized: (1) Biogerontological; (2) Social and behavioral; and (3) Applied studies of health and long term care. Formal training is provided in responsible conduct of research and conducting studies with minority populations. This training program is coordinated through the Penn State Gerontology Center. An interdisciplinary Training Committee is responsible for policies for this program, including review of applicants, monitoring progress of trainees, and coordination of the activities of the Faculty Preceptors. Trainees are selected from the 11 departments and programs which contribute Faculty Preceptors to this program. Eligibility includes having a Master's degree and commitment to a career in research in aging. The training program has been successful in attracting a large, talented pool of applicants. Recent trainees have a very high rate of completion of the program and of their doctorates, and have taken positions which maintain their involvement in research on adult development and aging.